Cell lysis-induced leukotriene synthesis activates type-2 immunity in the lung

Project Summary/Abstract
Treating, and in particular preventing, diseases requires an understanding of the mechanisms that lead to their
initiation. Parasitic worms and allergens all trigger a “type 2” immune response, but how these agonists are first
detected remains poorly understood. Group 2 innate lymphoid cells (ILC2s) are activated early in a type 2
immunity and coordinate downstream inflammation, but they do not directly sense worms or allergens. Instead,
ILC2s are activated by signals released from their surrounding tissue, such as the cytokine interleukin(IL)-33.
IL-33 is critical for airway type 2 immunity and its release has been linked to cell lysis caused by helminths and
many allergens. We have discovered that leukotriene C4 (LTC4) and its metabolite LTD4 are also universally
required for ILC2 activation and innate type 2 immunity in the lung. Which cells synthesize LTC4 and how this
is activated by helminths or allergens remains unknown. Here we test the central hypothesis that by
coordinating the release of both IL-33 and LTC4, loss of plasma membrane integrity (LPMI) serves as a
unifying mechanism for the induction of type 2 immunity. First, we identify alveolar macrophages as an
important source of LTC4 and study how LTC4 synthesis is regulated in these cells. Next, we examine the
unique contributions of LTC4 and LTD4 to acute and long-term ILC2 function and downstream type 2 immunity.
Lastly, we use novel tools to examine the link between lytic cell death and type 2 immunity in the lung. Our
work promises to uncover novel mechanisms regulating induction of type 2 immunity and will therefore suggest
novel therapeutic approaches to treat or prevent diseases such as asthma.

Public health relevance
Project Narrative Parasitic worms and allergens all trigger a type 2 immune response, but it remains unclear how they are initially detected by the immune system. We propose that loss of plasma membrane integrity coordinates the release of interleukin-33 and leukotriene C4, and is thus a unifying mechanism for the initiation of type 2 immunity. Understanding the fundamental processes of immune sensing will facilitate the design of new therapeutics and suggest strategies to prevent allergic disease.